Evaluate three v-SNAREs in regulated and constitutive TNF release from mast cells

PROJECT SUMMARY
Mast cell-derived TNF (tumor necrosis factor) plays important roles in immune responses, but when in
excess, causes inflammatory disorders including asthma and rheumatoid arthritis. Unlike other TNF
producing cells, mast cells pre-store TNF in cytoplasmic granules, which can undergo rapid
exocytosis/degranulation under specific conditions. Mast cells can also be activated to promote TNF
transcription, and newly synthesized TNF is released over time via constitutive secretory carriers such as
Golgi-derived vesicles. Both regulated and constitutive TNF secretion require specific interactions
between vesicle/granule-anchored SNAREs (v-SNAREs) and SNAREs anchored to the plasma
membrane (the target membrane; hence t-SNAREs), resulting in the formation of trans-SNARE
complexes and concomitant membrane fusion. Exocytic trans-SNARE complexes in immune cells are
typically composed of a VAMP (v-SNARE), a SNAP23 (t-SNARE) and a syntaxin (t-SNARE). However,
the identities of the SNAREs that underscore TNF release from activated mast cells are largely unknown,
which has hindered the understanding of the stimulus-specific regulation of TNF exocytosis in these cells.
The overall objective of this proposal is to uncover the missing v-SNAREs required in regulated and
constitutive TNF secretion from primary mast cells. New evidence from our lab has suggested that TNF is
associated with exosomes within MVBs (multivesicular bodies; a type of late endosomes), which rely on
VAMP7 or Ykt6 (a unique, multi-purpose v-SNARE) to fuse with the plasma membrane. Meanwhile,
VAMP2 has recently emerged as the v-SNARE that mediates the exocytosis of Golgi-derived vesicles.
Based on these fresh insights, we hypothesize that mast cells employ VAMP7/Ykt6 and VAMP2 to
release prestored and newly synthesized TNF respectively in response to different environmental cues.
To test this hypothesis, we will exploit primary mast cells derived from KO mice and their wildtype
littermates to pursue two specific aims. Aim1 will assess the requirement of VAMP7 and Ykt6 in
acute/regulated TNF exocytosis. Aim2 will assess the requirement of VAMP2 in constitutive TNF
exocytosis. The completion of this study will delineate the catalytic machineries that drive TNF
exocytosis under different environmental conditions, setting a stage for revealing stimulus-specific
regulation of TNF release unique to mast cells.

Public health relevance
PROJECT NARRATIVE Mast cells release tumor necrosis factor (TNF) that plays critical roles in innate immunity as well as allergic inflammation. In this proposal, we investigate the molecular mechanisms that underscore TNF release via distinct secretory pathways. The completion of the proposed work will shed light on new therapeutic strategies that selectively target TNF secretion in allergic inflammation without interfering with TNF secretion in innate immune response.